PREMISE: Pandemic Response Repository through Microbial and Immune Surveillance and Epidemiology

PREMISE is a proactive pandemic preparedness program to establish a stockpile of tangible immunobiological countermeasures to accelerate the response to pandemic threats globally
PREMISE assesses immune responses against known and novel viruses in targeted human populations
PREMISE translates these data into diagnostic, therapeutic and prophylactic assets

Deliverables:
Reagent and data resources for early detection and diagnostic assays
Monoclonal antibodies with potential for prevention and therapy
Immunogens suitable for vaccine discovery and development

Activities:
Conduct genetic analysis of zoonotic reservoirs and symptomatic humans for pathogen discovery
Develop high throughput, multiplexed serologic and cellular immune assays
Identify antigen-specic and cross-reactive immune responses to known and novel viruses in strategically targeted cohorts
Establish and expand in-country laboratory assay capabilities